Contextual Data Acquisition and Analysis Core

The Contextual Data Acquisition and Analysis Core, one of two research support cores in the Center for the
Study of Adolescent Risk and Resilience (C-StARR), will support funded projects by providing access to the
technology and expertise needed to enhance and extend the collection, management, and analysis of data
relevant to the relation between self-regulation and substance use during adolescence and early adulthood.
Core staff will support the work of Center-affiliated scholars by 1) encouraging and supporting the acquisition of
data characterizing the physical, social, and cyber contexts that shape adolescents’ behavior; 2) offering
access to the population and records of public school students in North Carolina; 3) providing the data
collection and data management support required for innovative, high-impact projects; 4) providing access to
expertise and training in novel approaches to modeling and analyzing complex data; and 5) collaborating on
projects that result in high-impact manuscripts and presentations and successful grant applications. The Core
will be led by Drs. Kenneth Dodge and Candice Odgers, senior scientists with distinguished records of
scholarship on the role of contextual factors in the development of substance abuse and other maladaptive
behaviors. A Core Advisory Group will provide input on emerging strategies for collecting, managing, and
analyzing data and, as needed, connect Core staff with faculty and professional-staff experts in these areas.
Longstanding partnerships with the Social Science Research Institute and the North Carolina Education
Research Data Center will allow Core staff to connect Center-affiliated scholars to additional sources of data
and research support.